Cancer Center Support Grant: Developing Global Measures of Cancer Stigma

PROJECT ABSTRACT
Cancer is a large and growing problem among people living with HIV (PLWH). PLWH are far less likely to
receive cancer treatment compared to uninfected counterparts. Even PLWH that receive cancer treatment
experience worse cancer survival, suggesting that there are additional drivers of outcomes disparities. The
disparity in cancer treatment and survival is especially concerning given the near normal life expectancy of
PLWH in the era of antiretroviral therapy and the mortality burden faced by PLWH who develop cancer.
Although PLWH experience more clinician-reported cancer treatment toxicity leading to early discontinuation of
cancer treatment and hospital admission, little is known about the patient perspective of cancer treatment
toxicity. Patient-reported outcomes (PROs) provide unique information on how delivered care affects patient
health and well-being, and are predictors of poor cancer outcomes in the general cancer population. In Aim 1,
we will assess the type, frequency, and severity of PROs for PLWH compared to cancer patients without HIV
using the validated PROMIS to measure physical, mental, and social health for all cancer sites. We
hypothesize that PLWH with cancer will experience more frequent and severe symptoms compared to HIV-
negative cancer patients. In Aim 2, we will examine the relationship between PROs and cancer outcomes,
including treatment completion, treatment delays, inpatient admission, cancer recurrence and survival. We
hypothesize that higher patient-reported symptom burden will be associated with adverse treatment outcomes,
particularly among PLWH. This retrospective study will identify disparities in cancer treatment toxicity for
PLWH and HIV-negative cancer patients utilizing a validated PRO and measure associations between toxicity
and real world clinical outcomes. Early identification and management of cancer treatment side effects will
improve patient-centered, personalized and equitable cancer care for PLWH, thereby reducing cancer
disparities and improving survival for this marginalized population.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it addresses disparities in cancer outcomes among people living with HIV by generating actionable research to improve the provision of cancer care to this vulnerable population. The NIH HIV/AIDS Research Priorities and Guidelines for Determining AIDS Funding (NOT-OD-15-137, NOT-OD-20-018) has designated “Research to Reduce Health Disparities” as a high priority area. Our proposal addresses this priority and will generate fundamental insights needed to improve equity in cancer care and outcomes for this population.